Lipotoxic Protective Response of the Endoplasmic Reticulum

Lipid homeostasis is crucially important for cells, and disruptions in this balance can lead to diseases of lipid overload,
such as obesity-related disorders. Lipid homeostasis is mainly coordinated in the endoplasmic reticulum (ER), the largest
membrane system in cells. The ER is a well-recognized location for synthesis of membrane and secreted proteins,
processes that are safeguarded by the “unfolded protein response” (UPR). Recent studies suggest that a complementary
and interrelated pathway, which we term the “lipotoxic protective response” (LPR), acts in parallel to maintain ER lipid
homeostasis. In contrast to the UPR, however, knowledge of the molecular aspects of the LPR remain rudimentary. Here
we describe studies to overcome this knowledge gap through investigations through our recent identification of the
mammalian FIT2 protein as a key guardian of ER lipid homeostasis. FIT2 has been a mysterious ER protein, of crucial
importance for cell health and function, that was implicated in ER homeostasis and lipid metabolism but lacked an
identified function. After years of effort and a biochemical tour de force, we have discovered that FIT2 is an acyl-CoA
diphosphatase enzyme that catabolizes fatty acyl-CoAs, the activated forms of fatty acids, in the ER. Our preliminary data
indicate that this activity may be localized on the luminal leaflet and is crucially important for cell health and viability.
Absence of FIT2 triggers ER stress and, in a mouse model we have generated, liver injury. Our findings break new ground
and raise many important questions about FIT2 and the LPR. Here we propose to answer these questions by using an
interdisciplinary approach. Aim 1 will determine mechanisms of the LPR at the molecular level by deciphering the
biochemical mechanism for FIT2’s catabolism of fatty acyl-CoA in the ER. We will combine biochemical and structural
biology approaches to answer: What is the enzyme’s catalytic mechanism? Is FIT2 active towards ER luminal substrates?
Is its activity regulated by lipid metabolites (e.g., diacylglycerol, DAG)? What is the fate of the metabolites generated by
FIT2 activity? Aim 2 will determine mechanisms of the LPR at the cellular level by elucidating how FIT2 and the LPR are
integrated with other ER stress protection pathways. Specifically, we will address: How does FIT2 mechanistically trigger
the UPR? Does the mammalian UPR pathway depend on FIT2 activity? Can the interdependency of the FIT2/LPR and the
UPR be exploited for therapeutic purposes in cancer, for example those with high demands on ER function, such
hepatocellular carcinoma and multiple myeloma? Aim 3 will determine mechanisms of the LPR at the physiological level
by determining how FIT2 maintains lipid homeostasis in mammalian liver. We have generated mice lacking FIT2 in
hepatocytes, and preliminary studies indicate these mice have ER stress, increases in hepatocyte lipid storage, defects in
lipid secretion, and signs of liver disease. We will mechanistically dissect this phenotype to elucidate how FIT2 is
required in cellular lipid metabolism. Completion of these aims will reveal how a fast, enzymatic mechanism functions in
the LPR to protect cells and maintain lipid homeostasis. It will also shed light on the pathogenesis of human disease, such
as the rare human disorder of FIT2 deficiency and more common metabolic diseases involving ER lipid metabolism, with
implications for both liver steatosis and cancers that rely heavily of the ER (such as liver cancer and multiple myeloma).

Public health relevance
Project Narrative To function normally, cells must coordinate fat or lipid metabolism and much of this coordinating occurs in an organelle called the endoplasmic reticulum. We recently discovered the biochemical reaction of an enzyme in this cell compartment called FIT2, which is required for health of cells or metabolic tissues, such as the liver. The projects of this proposal are aimed at understanding how this enzyme works to coordinate cellular lipid metabolism, how cells and tissues malfunction when the enzyme is deficient, and how reduced levels of this enzyme relates to metabolic disease and cancer metabolism.